Procoagulant platelets as biomarkers for post-COVID-19 cognitive decline

Post-COVID cognitive impairment is common after SARS-CoV-2 infection regardless of acute disease
severity. Mechanisms are poorly understood, limiting our ability to prevent cognitive decline for a growing
number of veterans. Identifying markers of risk for cognitive decline in post-COVID-19 syndrome is crucial for
effective prevention and treatment strategies. Silent brain infarctions (SBIs), covert cerebrovascular events
associated with risk of cognitive impairment, are prevalent in COVID-19 survivors. Although mechanisms are
unclear, it is plausible that they are ischemic manifestations of platelet hyperreactivity in COVID-19. Coated-
platelets, a strongly procoagulant subset of platelets produced after co-activation with collagen and thrombin,
are associated with ischemic stroke risk and the presence and number of SBIs on brain imaging from patients
with vascular risk factors. Preliminary work from VA funded research in veterans with COVID-19 showed that
increased coated-platelet levels predicted death at 90 days. In survivors, SARS-CoV-2 infection significantly
altered platelet procoagulant potential, with a sharp and sustained increase in coated-platelet levels noted
during convalescence. RNA sequencing in platelets obtained during acute infection identified an association
between pannexins and coated-platelet levels. In the same cohort, 39.4% reported brain fog symptoms a year
after infection, and 58.6% screened positive for cognitive impairment on the Montreal Cognitive Assessment
(MoCA) at 14 months. Importantly, mean coated-platelet levels measured during acute infection were
significantly inversely associated with future MoCA score. Lastly, in a separate cohort of veterans with mild
cognitive impairment, SARS-CoV-2 infection and age were significant predictors of progression to dementia at
18 months. Comparison of brain imaging before and after SARS-CoV-2 infection showed accumulation of new
SBIs following infection in those who progressed. Our central hypothesis, supported by our preliminary
findings, is that cognitive dysfunction in veterans with post-COVID-19 syndrome is mediated by accumulation
of SBIs, which is accelerated among those whose coated-platelet levels are elevated during and after SARS-
CoV-2 infection. Our long-range objective is to develop strategies for preventing cognitive decline after
recovery from COVID-19. The objective of the current application is to determine the role of coated-platelets as
predictors of cognitive dysfunction and SBI after recovery from COVID-19. Three specific aims will test our
hypotheses. Aim 1 will confirm and extend our preliminary findings showing an association between coated-
platelet levels and cognitive dysfunction after recovery from COVID-19. Coated-platelet levels will be assayed
in veterans with a history of SARS-CoV-2 infection, and the association between 1) cognitive impairment on
formal neuropsychological testing and 2) the presence of SBI on MRI determined. Aim 2 will characterize the
longitudinal relationship between coated-platelet levels measured every 6 months after enrollment in Aim 1,
and 1) the rate of cognitive decline on repeat neuropsychological testing and 2) the incidence of SBI on repeat
MRI at 18 months. Aim 3 will test the hypothesis that platelet pannexins are associated with coated-platelet
levels in veterans with cognitive manifestations of post-COVID-19 syndrome. Platelet pannexin-1 and
pannexin-2 mRNA and protein levels will be measured using RT-qPCR and ELISA in blood from subjects
enrolled in Aim 1 and compared with coated-platelet levels. Concurrent non-infected controls and historical
(pre-pandemic) controls will be used for comparison purposes. Considering the older age and vascular risk
burden among veterans, and the substantial impact of soaring cognitive impairment rates after the SARS-CoV-
2 pandemic, risk stratification and intervention strategies to prevent post-COVID cognitive decline have the
potential for enormous benefit. This project utilizes a new paradigm of prothrombotic platelet reactivity to
develop an innovative blood biomarker approach that will also yield novel treatment targets if successful.

Public health relevance
Post-COVID-19 syndrome is frequent in COVID-19 survivors regardless of acute disease severity. Cognitive impairment, a severely disabling manifestation of post-COVID-19 syndrome, poses particularly difficult challenges for our aging veteran population. Identifying markers of risk for cognitive decline after COVID-19 is crucial for developing effective prevention and treatment strategies. This project will characterize changes in cognition and brain imaging over time and will confirm the association between a platelet biomarker and future risk of cognitive dysfunction after recovering from COVID-19, resulting in better medical care, improved quality of life and decreased financial burden for the VA.